CACHET - IHSFC

1. INTEGRATED HEALTH SCIENCES FACILITY CORE: ABSTRACT
The Integrated Health Sciences Facility Core (IHSFC) will provide infrastructure and highly focused trans-
disciplinary services to CACHET members including access to cohorts and bio-banking; environmental health
sciences (EHS) design, implementation and translational study services; innovative approaches to population
exposure estimation using both traditional and cutting-edge techniques including device, sensors and wearables
and mobile app technologies; and novel statistical services with a focus on challenges in geospatial modeling
and evaluation of mixtures. This array of services will provide tools to translate fundamental research into
knowledge supporting disease prevention and the mitigation of racial/ethnic environmental health disparities.
The IHSFC will have leadership at both University of Illinois at Chicago (UIC) and University of Chicago (UofC),
and will build upon the existing research resources at these institutions to ensure that Core support is used to
develop additional key resources for conducting EHS work. Many of the resources that the IHSFC uses to meet
the EHS translational research needs of CACHET investigators that exist at our two institutions have been
modified, enhanced, centralized and efficiently organized between the two institutions by leveraging the
institution-specific strengths and growing Core resources. IHSFC personnel include experts in epidemiological
study design, population and clinic-based studies, specimen collection and quality assurance, exposure
technology and data analytics to support superior exposure assessment, and statistical methods relevant for
modern environmental health studies. IHSFC personnel will collaborate with personnel in the Environmental
Biomarkers Facility Core (EBC) to address molecular assay requirements involving biomarkers of environmental
exposures and environmental signatures in human biological materials. The IHSFC will also provide
interpretation of results and facilitate dissemination of the results to Chicago communities and beyond in
conjunction with the Community Engagement Core (CEC). In addition, the IHSFC will work with the CEC as well
as relevant Institutional CTSA and Cancer Center Cores to translate community-based EHS questions and
concerns into specific scientific hypotheses that may be supported by CACHET through the Pilot Project Program
(PPP). Furthermore, the IHSFC will facilitate projects that utilize the Human Health Exposure Analysis Resource
(HHEAR), to further enhance CACHET opportunities to conduct expanded target and untargeted analyses of
environmental relevance.